Chronic Antibody-Mediated Rejection of Kidney Allografts

ABSTRACT
Antibody-mediated mechanisms leading to acute and chronic renal allograft injury and loss remain poorly
understood. Investigation into these mechanisms is hampered by the lack of appropriate animal models to study
the development of allograft injury as the donor-specific antibody (DSA) response is initiated and progresses.
We have developed a novel model of antibody-mediated rejection (ABMR) of kidney allografts in CCR5-/-
recipients where DSA elicited in response to complete MHC-mismatched renal allografts are >50-fold higher
than the titers elicited in wild-type recipients. The allografts are acutely rejected by the DSA in CCR5-/- recipients
between days 17 and 22 with features that are virtually identical to those during acute ABMR of clinical kidney
grafts, including identical histopathology and gene expression signatures indicating NK cell activation. We have
recently demonstrated NK cell activation within the kidney allografts that is required for acute ABMR. In the
absence of NK cell activation, however, the high DSA titers induced in CCR5-/- kidney allograft recipients are
incapable of mediating acute ABMR but slowly induce development of tubular fibrosis and chronic glomerular
injury that leads to eventual graft failure similar to that observed during late failure of clinical kidney transplants.
Our preliminary results further indicate marked changes in the phenotype and functional transcriptome of graft
infiltrating monocytes and macrophages during chronic vs. acute ABMR. Development of the chronic ABMR is
also accompanied by the appearance of antibodies to several autoantigens that is not observed during acute
AMR. These results suggest the generation of altered myeloid cells and autoantibodies as key mechanisms
underlying the development of this chronic pathology and have led us to hypothesize that DSA binding to kidney
allograft endothelium in the absence of NK cell activation stimulates production of myeloid cell recruitment and
differentiation factors that skew their function to promote autoantibody production and development of chronic
antibody-mediated graft injury. This hypothesis will be tested in three specific aims. In Specific Aim 1 we will
test mechanisms of DSA-induced kidney allograft endothelial production of factors directing myeloid cell
recruitment and function during development of chronic ABMR. In Specific Aim 2 we will test the role and
functions of graft infiltrating myeloid cells that promote development of antibody-mediated allograft injury. In
Specific Aim 3 we will test the production and role of auto-antibodies in the development of chronic ABMR. The
proposed experiments will utilize novel and clinically relevant models of kidney allograft chronic ABMR to directly
identify the inflammatory components and their mechanisms mediating chronic injury of the kidney grafts late
after transplant. We anticipate that our studies will continue to reveal novel mechanisms critical to the
development of kidney graft chronic ABMR and to identify new therapeutic targets to inhibit or attenuate this
pathology and improve kidney graft function and survival.

Public health relevance
PROJECT NARRATIVE The incidence of acute and chronic antibody-mediated rejection (ABMR) is increasingly observed in clinical kidney transplants and effective treatment has become one of the most important challenges confronting successful long-term graft survival, but the mechanisms leading to the development of antibody-mediated chronic graft injury and loss remain poorly understood and are hampered by the absence of clinically relevant preclinical models. We have developed novel models of chronic ABMR of kidney allografts that we will utilize to test the hypothesis that in the absence of NK cell activation DSA binding to kidney allograft endothelium stimulates production of myeloid cell recruitment and differentiation factors that skew their function to initiate and promote autoantibody production and chronic graft injury leading to chronic ABMR. We anticipate that the results of the proposed studies will provide novel insights into the components and mechanisms underlying development of antibody-mediated chronic kidney graft injury and identify novel targets and therapeutic strategies to improve kidney graft outcomes.